Using Wearable Technology to Assess Recovery and Detect Post-Operative Complications Following Cardiothoracic Surgery

Project Summary. Every year, more than 500,000 patients undergo operations for heart and lung disease.
After surgery, patients often experience pain, fatigue, and disturbed sleep that can persist for weeks to months.
In addition, up to 32% of patients develop postoperative complications, which often occur after discharge from
the hospital and may lead to readmission. Complications are costly and can be deadly; they are associated
with a 200-300% increase in healthcare costs and a 6-fold increase in 90-day postoperative mortality.
Currently, after surgery, when a patient is discharged from the hospital, the patient and their family members
are responsible for monitoring the patient’s health status. Patients are usually not seen by a doctor for 2-4
weeks after discharge. Attempts to improve postoperative monitoring include home health visits and
telemedicine approaches. However, these methods have been shown to be ineffective, costly, and allow for
only vague and intermittent assessments of recovery. They do not detect complications until they are at a
more severe stage. As such, accurate, easy-to-implement and inexpensive methods to assess postoperative
recovery and to detect complications at their earliest stage—before symptom onset—are urgently needed.
We previously showed that machine learning analysis of biometrics collected by wearables could detect Lyme
Disease and Covid-19. We then, in a pilot study, applied our algorithm, previously developed to identify Covid-
19, to patients undergoing thoracic surgery and showed that this algorithm could detect 89% of complications a
median of 3 days before symptom onset. When we evaluated the postoperative recovery of cardiothoracic
patients, we showed that machine learning analysis of biometrics could classify patients into distinct recovery
groups. Thus, wearables and machine learning algorithms could lead to a highly accurate and accessible
method to predict complications early and improve assessments of recovery.
Our overall objective is to optimize and validate our machine learning algorithm—previously developed for the
early detection of Covid-19—for the detection of postoperative complications prior to symptom onset and to
use machine learning analysis to predict the quality of a patient’s recovery using pre- and intraoperative data.
Our project aims to first use wearables to collect high-resolution physiologic data of cardiothoracic surgical
patients. We will then extend our previously developed algorithm for early detection of postoperative
complications and develop an algorithm to predict the quality of a patient’s postoperative recovery.
The proposed project will develop an innovative method to detect postoperative complications prior to
symptom onset and predict the quality of a patient’s postoperative recovery using pre- and intraoperative data.
Importantly, our proposed method could be scaled to not only improve outcomes for cardiothoracic surgical
patients, but for patients undergoing other types of surgery. The results of this study will enable a future
randomized trial that evaluates whether real-time postoperative monitoring with machine learning algorithms
and wearables can lead to 1) earlier detection of complications, 2) earlier outpatient interventions that improve
recovery and/or reduce severity of complications, and 3) decreases in unplanned hospital readmissions.

Public health relevance
Project Narrative. Every year, more than 500,000 patients undergo cardiothoracic operations for heart and lung disease. After surgery, patients suffer from pain, fatigue, and disturbed sleep for weeks to months and up to 32% of patients develop postoperative complications which lead to unplanned readmissions and a 6-fold increase in mortality risk. The overarching goal of this research is to use machine learning analysis of high- resolution physiologic data—collected by wearable technology—to detect postoperative complications at their earliest, subclinical stage, prior to symptom onset and predict the quality of a patient’s postoperative recovery. The use of such algorithms for cardiothoracic surgery patients will have significant public health impact, potentially enabling earlier detection of postoperative complications, greater reduction in the severity of complications, earlier outpatient intervention that can improve recovery, and/or greater decreases in unplanned hospital readmissions.